Developmental Funds

Developmental Funds - Project Summary/Abstract
Developmental Funds provide the Cancer Center Director the opportunity to identify and recruit new young
investigators into the Cancer Center, helping to expand the research initiatives of the Center. Pilot Grant
awards provide a mechanism for the Director to promote and steer collaborative projects into new and exciting
translational and technological areas. The use of Developmental Funds is determined by the Director with input
from the Senior Leadership. The use of these funds has proven to be very successful. The investigators who
have received funds over the course of this CCSG now in year 45 have been highly successful and remain in
the Salk Cancer Center, as evidenced by the fact that all but one member of the current leadership were at one
time recipients of these funds. In addtion to the New Investigators Program and Pilot Grant Program
Developmental Funds have supported the building of several new Shared Resources over the past 15 years.
Developmental Funds have been foundational to the success of Salk Cancer Center.